Tricuspid Valve Maladaptation: Its Stimuli, its Effect on Valve Function, and its Response to Therapy

ABSTRACT. Tricuspid valve regurgitation severely impacts more than 1.6 million Americans. In most patients,
tricuspid regurgitation is considered “functional” or due to valve-extrinsic factors. The valve itself is considered
intact and thus viewed as an innocent bystander. Therefore, most treatment strategies focus on these valve-
extrinsic factors and ignore the valve itself. Recently, we have shown that tricuspid regurgitation may not be so
functional after all. In two separate sheep models of functional tricuspid regurgitation, we showed that the
tricuspid valve leaflets fibrotically remodel, i.e., maladapt. Those leaflets grow in area and become both thicker
and stiffer. Through computational studies, we further showed that maladaptation reduces leaflet compliance
and their ability to coapt successfully, thus impeding valve function. These findings are of critical importance as
tricuspid maladaptation may be a predictor for disease progression and patient outcomes. They may also explain
the limited success of current treatment strategies. That is, they may explain why tricuspid valve repairs fail long-
term in as many as 30% of patients. The ultimate goal of the parent grant is to understand tricuspid valve
maladaptation as a potential therapeutic target. In fact, Aim 3 of the parent grant explores prophylactic surgery
as one potential path toward preventing maladaptation and thus improving clinical outcomes. Instead, the
objective of this supplement is to take a first step toward testing tricuspid maladaptation as a pharmacological
target for future therapies. Therein, we are guided by our and others’ findings that remodeling of cardiac valve
leaflets occurs through disease-induced endothelial-to-mesenchymal transition (endoMT) of valvular endothelial
cells (VEC) and valvular interstitial cell (VIC) activation. Both phenotype changes have been suggested to be
mediated through the renin-angiotensin system (RAS). Toward identifying a pharmacological target for tricuspid
valve maladaptation, we thus test the hypothesis that targeted RAS inhibition suppresses the direct and indirect
activation of tricuspid valve cell phenotypes that drive tricuspid valve maladaptation. Specifically, in Aim 1, we
will test RAS-mediated VEC endoMT and VIC activation as a potential pharmacological target in-vitro. Thereby,
our work is a critical step toward a translatable treatment and directly informs future in-vivo studies. For example,
in the mitral valve, Losartan, an angiotensin II receptor inhibitor, has shown some promise to treat mitral
maladaptation. Based on our work, we may be able to similarly identify safe drugs that can be used to suppress
tricuspid valve maladaptation. Our effort will shed new light on a deadly cardiovascular disease and its treatment
and is thus well-suited for support through the CAROL Act.

Public health relevance
PROJECT NARRATIVE. Leakage of the tricuspid valve, located between the right atrium and right ventricle, is extremely common and can significantly impact patients' health. We have recently found a new disease mechanism that may explain the failure of current treatment strategies. The goal of this supplement is to demonstrate that this disease mechanism can be targeted and suppressed with drugs and to pave the path for future pharmacological treatment strategies.